Administration

The overall objective of administrative Core A is to provide this multi-PI, multi-institutional U19 IPCAVD Project
the opportunity to interact synergistically by facilitating the communication among the Project Leaders and all
participating scientists. Core A will also serve as liaison between Research Administration at the contact
institution, the Texas Biomedical Research Institute (TxBiomed), all the affiliated institutions both in the US and
in Europe, and NIAD representatives. The network of partnering scientists includes researchers in Texas,
Louisiana, Georgia and several countries in Europe; the major partner is Mymetics in Switzerland. The innovative
biotech company has developed gp41-based virosomes into to a novel vaccine platform that is cold-chain
independent and can be administered mucosally without needles.
The Specific Aims of Core A are to:
1. Provide administrative support and facilitate the collaboration among Projects 1 and 2 and the various
subcontract/subaward leaders and partners. This will include the exchange of information, reagents, and
material transfer agreements.
2. Set priorities, monitor progress and jointly make go/no-go decisions. This will be achieved with input
from the External Scientific Advisory Board (ESAB) and the NIAID IPCAVD Program Officer.
3. Assist in the design of experiments in rhesus macaques (RMs), protocol design and submission, and
exchange of samples between the New Iberia Research Center (NIRC), where the primate studies will
be conducted, and TxBiomed.
4. Provide statistical support for all IPCAVD scientists through the participation of Dr. Sarah Ratcliffe
through a subaward with the University of Virginia (UVA).
5. Provide financial oversight and assure prompt payment of bills as well as the timely achievement of the
experimental goals within budget limits.
6. Organize the yearly NIH Site Visit and the External Scientific Advisory Board (ESAB) meeting in the
Washington, D.C. area, as well as individual visits between Drs. Ruprecht, Villinger, Santangelo and
Fleury.
7. Address intellectual property (IP) issues fairly, timely, and equitably.
8. Facilitate the submission of reports, dissemination of data at meetings, and publication of manuscripts.
To meet the goals of this translational, highly interactive U19 Research Program, the Core A Leader/Contact PI
depends on the trained professionals with excellent organization skills as well as basic understanding of science
and medicine to make this U19 network of scientists successful.